Acquisition of high-parameter fluorescent-activated cell sorter analyzer

ABSTRACT
We are requesting funds to purchase a BD FACSymphony S6 SE Spectral Cell Sorting Platform (hereafter
‘Symphony S6 SE’) to advance our clinical and translational research at The Feinstein Institutes for Medical
Research (FIMR).
The FIMR is the research arm of Northwell Health, the largest healthcare system in New York and home to
approximately 75 research labs, 3,000 clinical research studies and 5,000 researchers. The Flow Cytometry and
Imaging Core Facility (Flow Core) is the only resource that provides cell sorting services to researchers at
Northwell Health. We are requesting funds to purchase a Symphony S6 SE cell sorter that can sort 6 different
populations using up to 50 different parameters, a capability we do not currently have. The Symphony S6 would
allow our researchers to isolate specific, rare cell populations that require high-parameter sorting with complex
gating strategies. This instrument has low signal to noise ratio, sensitive PMT detectors finely tuned to the
appropriate wavelengths and optimal breakoff and pausing technology to ensure purity of sample. The
Symphony S6 SE offers flexibility in types of collection tubes or plates and the ability to change collection tubes
without stopping the sort. The Symphony S6 SE cell sorter also has an integrated biosafety cabinet with an
independent aerosol management system which is particularly advantageous for sorting human cells and virally
infected cell populations.
This proposal features highly relevant clinical and translational projects aimed at discovering molecular pathways
leading to novel treatments, with higher efficiency and fewer side effects in autoimmune disease, cancer, and
hematological disorders that are being studied in 8 NIH-funded projects. Researchers will use the instrument to
obtain information from sorted cells for downstream applications with greater efficiency, and additional analysis
parameters unavailable from the cell sorters currently operating at the FIMR. Furthermore, the 6-way sorting
capability of the Symphony S6 is critical to maximizing the use of precious patient samples as it permits
simultaneous sorting of 6 cell populations, including rare cell populations. Our current instruments are soon to
be retired and are restricted to sorting 4 populations, with less high-resolution, necessitating the availability of
more starting material.

Public health relevance
PROJECT NARRATIVE This proposal is for acquisition of a high-parameter fluorescent-activated cell sorter analyzer to support research in diseases for which cures do not presently exist and represent a significant burden to public health including autoimmune diseases, chronic lymphocytic leukemia, and hematological disorders.